MEGESTROL ACETATE ON APPETITE IN CHILDREN W/ FAILURE TO THRIVE

A pilot study to determine the effect of megestrol acetate on appetite and feeding behavior in children age 1-4 years with nonorgnaic failure to thrive, its impact on nutritional status, bone health and endocrine function.